Aerobic fitness as a modifier of neurodegeneration and cognitive decline in preclinical Alzheimer's disease

PROJECT SUMMARY / ABSTRACT
The prevalence of Alzheimer's disease (AD) is expected to rise significantly, reaching 15 million
individuals by 2060 in the US. AD-related brain and cognitive changes are evident several years before
symptom onset, in what is known as the preclinical stage. In the absence of disease-modifying treatments, it is
imperative that we identify and characterize lifestyle factors that could modify the course of the disease.
Greater aerobic fitness, objectively measured by VO2max, is considered a critical component of overall health
and a strong predictor of cognitive functioning. It may prevent or modify the progression of AD, as it has been
associated with stronger functional brain functioning and less amyloid and tau burden. It has also been shown
to reduce neuroinflammation, which further contributes to disease progression and cognitive decline. While
there is considerable evidence supporting the benefits of greater fitness in healthy aging, less is known about
how it impacts the progression of AD. Specifically, there is paucity of research investigating, 1) the relation of
fitness to AD-related brain pathology and functional connectivity; 2) the mechanisms that underlie the
relationship between fitness and memory functioning in AD; and 3) changes in AD-related brain pathology,
brain functioning and cognition associated with fitness overtime.
The candidate will capitalize on an ongoing NIA-funded observational longitudinal biomarker study with a
Colombian kindred with autosomal-dominant AD (ADAD), the world's largest family with a single mutation
(E280A) in the Presenilin-1 gene that leads to dementia. She will test the hypothesis that greater aerobic
fitness is associated with better brain functioning, less accumulation of brain pathology (tau and amyloid), and
less neuroinflammation in presymptomatic mutation carriers. Some consider that ADAD is the ideal model to
study preclinical changes associated with AD since mutation carriers, who are otherwise healthy (e.g. no
cardiovascular pathology), will invariably develop dementia. Thus, this provides the opportunity to investigate
the direct link between AD and aerobic fitness. To test the hypotheses, each participant will undergo PET
PiB (amyloid) and 18F T807 (tau), functional MRI at rest, cognitive testing, and lumbar puncture to examine
neuroinflammation as measured by a composite index of neuroinflammatory markers, at baseline and every
24 months. The candidate will obtain training in, (1) assessing aerobic fitness and understanding its relation to
brain health, (2) longitudinal analytic approaches, (3) multimodal imaging methods, and (4) assessing and
understanding the role of neuroinflammation in preclinical AD. She has gathered an exceptional team of
experts in aging and AD from the MGH, Harvard University and Northeastern University, who are fully
committed to helping her accomplish her research training and career development goals, as well as to ensure
her successful transition to an independent and productive career in aging research.

Public health relevance
PROJECT NARRATIVE Intervening in the preclinical stage of Alzheimer's disease (AD) may help delay or prevent further brain damage and cognitive decline. We will use state-of-the-art neuroimaging techniques (e.g. MRI, PET), cognitive assessments, and gold-standard measures of aerobic fitness, to characterize baseline and longitudinal relationships between aerobic fitness, markers of AD-pathology (e.g. amyloid and tau), network connectivity, and cognitive decline, as well as the potential moderating role of neuroinflammation, in a unique group of individuals with autosomal-dominant Alzheimer's disease due to a PSEN1 E280A mutation. Findings will help elucidate the mechanisms through which aerobic fitness may protect against AD to inform future interventions.